Altered inflammatory response associated with acquired DNMT3A mutations

PROJECT SUMMARY
The human gene DNMT3A encodes one of the three enzymes that carry out DNA methylation in
humans. Clonal expansion of blood cells with acquired mutations in DNMT3A is common in older adults,
occurring in 5-10 % of healthy individuals aged 60 or above. Carriers of DNMT3A mutations have an
approximately tenfold increased risk of developing hematologic cancers and are twice as likely to develop
coronary heart disease. Given the rapidly aging population in the United States and worldwide, understanding
the mechanistic basis of the association between acquired DNMT3A mutations in blood cells and increased
susceptibility to cancer and cardiovascular disease is tremendously important for public health. Recent studies
found evidence of increased inflammation mediated by myeloid cells when the ortholog of DNMT3A was
perturbed in animal models. However, the molecular mechanisms underlying this phenomenon and whether
DNMT3A mutations affect the inflammatory response of human myeloid cells remain poorly understood. To
address this gap in knowledge, we established an experimental system based on myeloid cells differentiated
from human pluripotent stem cells. Using this system, we found that human macrophages with DNMT3A
mutations displayed altered inflammatory response compared to wild-type macrophages, characterized by
augmented expression of IL-6, a potent proinflammatory cytokine. The IL6 promoter was one of the most
significantly hypomethylated loci in DNMT3A-mutated macrophages, suggesting a direct mechanistic link
between DNA methylation and inflammatory response in our model. In this application, we propose to
characterize the molecular signature of the inflammatory response associated with DNMT3A mutations using
genetically defined human macrophages and neutrophils and to dissect the epigenetic mechanisms underlying
DNMT3A-mediated gene expression regulation. In addition, we will examine the impact of harboring clonally
expanded blood cells with DNMT3A mutations on the inflammatory response of primary myeloid cells using a
novel single-cell transcriptomic technique. We are in an ideal position to pursue this project given the
availability of human pluripotent stem cell-based human myeloid cell models that we have developed and
validated, our access to a large biobank representing extremely diverse populations, and the assembly of a
strong scientific team consisting of investigators with complementary expertise. Findings from the proposed
study will provide critical new insights into the consequence of acquiring DNMT3A mutations on inflammation,
and help us develop novel strategies to prevent and treat pathologic conditions related to DNMT3A mutations.

Public health relevance
PROJECT NARRATIVE Clonal expansion of blood cells carrying acquired mutations in DNMT3A is common in older adults and associated with an increased risk of developing hematological malignancies and cardiovascular disease. Molecular mechanisms underlying these associations are poorly understood. The objective of this project is to examine the impact of DNMT3A mutations on the inflammatory response of human myeloid cells, with the ultimate goal of identifying novel therapeutic approaches for the prevention and treatment of inflammatory diseases associated with DNMT3A mutations.